Multimodal fusion for early prediction of Alzheimer’s disease: Request for supplemental funds for NIH R01: R01EB006841 “Multivariate methods for identifying multitask/multimodal brain imaging biomarke

Abstract
The relationship of Alzheimer's disease (AD) to the brain has been widely studied. Early diagnosis of AD is
challenging for multiple reasons, including the presence of variability in the clinical and pathological features
within affected individuals. In recent work we have shown a large improvement in sensitivity and stability of brain-
based biomarkers of various disorders using approaches that leverage the joint information across multiple mo-
dalities. In this work we focus on three promising directions including first the joint fusion of multiple functional
networks with brain structure by using a novel approach called parallel multilink joint independent component
analysis. Secondly, we will develop an approach to leverage a generative framework for capturing dimensional
changes in AD using an approach based on variational autoencoders, high order clustering, and meta-mapping
between latent space variables and colors. Finally, we will extend this work to move towards a low dimensional
prediction of AD risk by combining multiple large clinical datasets with large population datasets such as the
UKbiobank data and others. The proposed aims have the potentially to significantly increase the sensitivity of
imaging-based methods for predicting AD in unaffected individuals.

Public health relevance
Narrative The proposed supplement will link together structural and functional MRI data in order to assess risk for Alz- heimer's disease. We will focus on three main algorithmic extensions including linking of multiple functional net- works with structural covariation, generative modeling and mapping of multimodal data, and finally the develop- ment of a dimensional risk score. The approaches will be validated in several large N longitudinal aging and AD datasets.